SMALL MOLECULE THERAPEUTIC FOR ALZHEIMER'S DISEASE

An estimated one out of eight individuals over the age of 65 has Alzheimer’s disease (AD), with a
prevalence of 1-in-3 for those over age 85. There are approximately 5.8 million people in the USA
with AD, with a global projection of over 150 million by 2050. There remains a lack of effective
treatment to halt disease progression. Somatostatin receptor-4 (SSTR4) represents an innovative
and viable brain target for AD treatment. A SSTR4 agonist has the potential to mitigate AD pathology
via downstream enhancement of amyloid-beta metabolism, as well as the capacity to directly
enhance cognitive function. This program seeks to advance a first-in-class SSTR4 agonist drug for
AD treatment. The goal of this phase-I STTR is to establish an advanced lead SSTR4 agonist with
optimized physiochemical attributes for enhancement of brain uptake. An optimization process
based on SSTR4 structure-activity relationships has been undertaken. The approach is iterative and
as such each step informs the next with the data used to determine “go/no-go” advancement.
Compound design and screening includes state of the art computer-aided drug design, with
synthesized compounds screened against through an iterative process. A successful candidate
from this phase-I study will advance to the development phase, with GMP manufacturing of single
candidate, full IND-enabling evaluations, and formulation for clinical trials. The IND preparation and
FDA submission will precede clinical trials. This program demonstrates a clear intellectual property
pathway for commercialization. The goal and aims of this study address priorities of National
Institutes of Health, specific to PAR-19-317.

Public health relevance
Alzheimer’s disease (AD) is the most common type of dementia. Current medications have only modest clinical benefit and do not modify the course of the disease. The goal of this program is to advance a first-in-class somatostatin receptor subtype-4 agonist drug capable of mitigating AD pathology.